Human Acute Myeloid Leukemia Stem Cells

PROJECT SUMMARY
Acute myeloid leukemia (AML) is an aggressive malignancy of the bone marrow characterized by the
accumulation of immature myeloid cells defective in their maturation and function. AML affects more than
20,000 adults annually in the United States, most of them over the age of 65. Even with aggressive treatments,
five-year overall survival is between 30-40%, and much lower for those over age 65. Human AML shows
evidence of a hierarchical cellular organization, with a minor fraction of self-renewing leukemia stem cells
(LSCs) at the apex of this hierarchy. LSCs are defined as cells that are capable of initiating the disease when
transplanted into immunodeficient mice and can both self-renew by giving rise to leukemia upon serial
transplantation and also partially differentiate into non-LSC bulk blasts that are unable to self-renew. The
clinical significance of this leukemia stem cell model is supported by the finding that gene expression
signatures of AML LSCs are independently correlated with adverse clinical outcomes. Detailed characterization
of AML LSCs has demonstrated their properties of self-renewal, relative quiescence, resistance to apoptosis,
and increased drug efflux that likely render them less susceptible to conventional therapies aimed at the bulk
proliferative disease. Thus, the generally poor clinical outcomes in AML are attributed to chemotherapy-
resistant LSCs that persist during clinical remission, eventually giving rise to relapsed disease. From a
therapeutic perspective, this cancer stem cell model implies that in order to eradicate the disease and achieve
long-term remissions, treatment approaches must eliminate the LSC population. Although initially described
several decades ago, AML LSCs have not been rigorously purified primarily due to the extensive heterogeneity
of primary human AML and limitations of available xenotransplantation models. Functional LSCs have been
found to be enriched in the CD34+CD38- fraction of leukemic cells, but are also present in other
immunophenotypic populations. A number of cell surface markers have been characterized on these AML
LSC-enriched fractions, but none are specific for LSCs or facilitate their rigorous purification. These results
have made it difficult to further characterize LSC biology and to develop methods for more specific therapeutic
targeting. While the field of human AML LSCs has a rich history of investigation, many key questions remain to
be addressed. Can LSCs be more rigorously identified and isolated based on cell surface marker expression?
What features or programs of LSCs are associated with clinical outcomes? How do adversely prognostic LSC-
associated genes regulate LSC functions? Do non-LSC blasts affect the properties of LSCs? Do AML
subpopulation dynamics affect LSC properties? This proposal seeks to address these questions through the
investigation of human AML LSCs based on the hypothesis that LSCs exhibit distinct functional properties and
biological programs that contribute to AML pathogenesis, response to therapy, and clinical outcomes.
Therefore, these LSCs represent the critical cellular target for the development of curative therapies.

Public health relevance
PROJECT NARRATIVE Human AML shows evidence of a hierarchical cellular organization, with a minor fraction of self-renewing leukemia stem cells (LSCs) at the apex of this hierarchy that must be eliminated to eradicate the disease and achieve long-term remissions. Although a number of cell surface markers have been characterized on AML LSC- enriched fractions, none are specific for LSCs or facilitate their rigorous purification making it difficult to further characterize LSC biology and to develop methods for more specific therapeutic targeting. This proposal seeks to rigorously characterize LSC properties and identify biological programs that contribute to AML pathogenesis, response to therapy, and clinical outcomes.